Core A: Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core (AC)
In our currently active Translational Research Program in Cancer Differences across Populations (TRPCDP) funded as a P20 SPORE planning grant, the Administrative Core (AC) has built a strong foundation for collaborative research via establishing partnerships with multiple institutions that has enabled us to evaluate colorectal cancer (CRC) differences across population groups who experience vastly different CRC incidence and mortality rates. The AC of the TRPCDP SPORE will support and integrate the activities of all research projects, the Biospecimen and Pathology Core (BPC), the Biostatistics and Bioinformatics Core (BBC), the Career Enhancement Program (CEP), and the Developmental Research Program (DRP) to maintain and grow our program in CRC research. Central to the AC’s function is the coordination of work across the following entities:
1. All TRPCDP investigators
2. Partnering institutions serving large numbers of population groups of cancer patients.
3. Our Community Advisory Board (CAB), External Advisory Board (EAB), and Internal Advisory Board (IAB)
4. Review panels evaluating applications to the CEP and DRP
5. Representatives of the National Cancer Institute (NCI)
6. New external partnerships built through this program including, but not limited to, those involving existing SPOREs, other funded programs studying differences in incidence and mortality and commercial entities.
This Core has the following specific aims:
Aim 1. Leadership: To provide the organizational structure and scientific and administrative leadership needed for the successful execution and evaluation of key TRPCDP objectives.
Aim 2. Administrative Management: To provide administrative management of all SPORE components including fiscal oversight, regulatory compliance, SPORE leadership succession plans, communication, data management, and engagement with NCI.
Aim 3. Incorporation of the P50 Program with the host institutions: To coordinate TRPCDP activities with various projects, programs, and shared resources at partnering institutions such that collaboration with these existing center resources will successfully support the TRCPDP.
Aim 4. Planning and evaluation of SPORE activities: To plan SPORE activities, assist with and prepare progress reports, organize regular CAB/EAB/IAB meetings, and support evaluations conducted by our Advisory Boards.
Aim 5. Sustain collaborations: To develop and support multi-center intra- and inter- SPORE interactions and initiate and sustain collaborations with key external partners.

Public health relevance
PROJECT NARRATIVE – Administrative Core (AC) The successful functioning of our Translational Research Program in Cancer Differences across Populations (TRPCDP) is highly dependent upon a capable and effective Administrative Core (AC). The AC will be vital for providing the requisite foundation for effective implementation of TRPCDP’s scientific and translational goals. This Core will provide overall leadership and administrative support, program management, incorporation with existing programs and shared resources, infrastructural support, communication within and across TRPCDP investigators and partnering institutions, and evaluation of all TRPCDP activities and components.